RELATIONSHIP OF SLEEP APENA AND BRAIN FUNCTION

The aims of this study are 1) to document abnormalities in the brain of patients with OSAS through the use of objective, electrophysiological and neuropsychological measures; 2) to locate those abnormalities through the direct measure of neural activity (topographic EEG mapping and evoked potentials) and neuropsychological information regarding deficits in specific kinds of psychological processes.